Identifying LC3 binders to develop lysosome-targeting chimeras

The NCATS Early Translation Branch (ETB) hosts a broad and comprehensive program for the discovery of drug candidates directed towards rare diseases and pharmacological tools to probe the function of the human genome. ETB conducts research to understand the underlying principles driving the translation of basic research discoveries into tangible improvements in human health.

During this reporting period, the project team has developed and optimized a high-throughput screening assay to detect LC3 binders utilizing a reporter construct. High-throughput screening is underway, while virtual screening was performed to identify small molecules that fit into the LIR-binding site within LC3.